Sex-specific dendritic spine and microglia pathology in depression

Abstract
Major depressive disorder (MDD) is a leading cause of disability, affecting more than 300 million people
worldwide. There is a well-known sex difference in incidence of MDD, with women being twice as likely to be
diagnosed as men. Additionally, the impact of MDD varies between men and women, with sex differences in
symptomatology, severity, and number of symptoms. For instance, women are three times more likely to have
atypical depression, characterized by hypersomnia and weight gain. These marked differences in
symptomatology between depressed men and women led us to hypothesize that MDD differs at the molecular
level between men and women. We recently assessed the sex-specific molecular pathology of MDD using
human postmortem brain analysis. We showed, for the first time, that depression is not only distinct in men and
women, but is characterized by opposite molecular pathology. The strongest opposite effects were in the
anterior cingulate cortex (ACC; Brodmann area 25), a brain region consistently implicated in MDD pathology.
Our analysis of men with MDD found reductions in markers of synaptic function and increases in markers of
microglia and inflammation, consistent with reports of decreased pyramidal cell dendritic spine synapses and
increased reactive microglia in depressed men. The molecular changes in MDD males are consistent with a
model in which reactive microglia participate in excessive pathologic synapse removal. Surprisingly, our
analysis of women with MDD found increased markers of synaptic function coupled with decreased markers of
immune function and microglia, which is exactly the opposite of depressed men. However, no study has
examined pyramidal cell dendritic spine and microglia changes specifically in depressed women, leaving a
major gap in the depression literature. Together, these studies suggest pyramidal cells and microglia are
affected in MDD, but in opposite directions in men and women. Notably, studies in rodents report that chronic
stress increases reactive microglia and decreases prefrontal cortex dendritic complexity in males, but does
exactly the opposite in females. Thus, rodents provide an excellent model system to probe molecular
mechanisms underlying the sex-specific pathology observed in human MDD. Here, we will assess pyramidal
cell dendritic spines and reactive microglia in the ACC of men and women with MDD, addressing a major gap
in the literature (Aim 1). Next, we will assess pyramidal cell- and microglia-specific transcriptional changes that
occur in depressed men and women (Aim 2). Finally, we will determine the functional relevance of observed
sex-specific MDD spine and microglia pathology using mouse models (Aim 3). These studies are essential for
understanding sex- and cell type-specific MDD pathology and determining if these sex differences drive MDD
symptoms. In addition, they will assess whether sex-specific treatments alleviate depression-related symptoms
and provide key insights for future sex-specific treatment development.

Public health relevance
Project Narrative Major depressive disorder (MDD) is a leading cause of disability with well-known sex differences in incidence and symptomatology. This proposal will help uncover sex-specific pathological changes that occur in the brains of patients with MDD. A better understanding of sex-specific brain pathology in MDD will provide key insights for future sex-specific treatment development.